Therapeutic Electrical Stimulation Using Wireless, Resorbable Implants to Accelerate Diaphragm Muscle Reinnervation after Phrenic Neuropathy

Project Abstract:
Phrenic Neuropathy, a condition that impairs diaphragm muscle function, often leads to serious
respiratory problems and requires mechanical ventilation. Our research proposal aims to enhance
recovery from this condition through a novel Therapeutic Electrical Stimulation protocol, in
conjunction with a custom-made, wireless, bioresorbable implant. Informed by a rising incidence
of Phrenic Neuropathy due to complications from severe COVID-19 and greater diagnostic
capabilities and other factors, this proposal is the result of collaboration among a multidisciplinary
team with substantial expertise in all aspects of this proposed work. In general, there is a common
misconception that recovery from peripheral axon injury is usually good, due to the fact there is
some spontaneous axon regeneration, but this does not match the reality that recovery is actually
slow and incomplete for approximately 90% of patients. This is also true for patients with Phrenic
Neuropathy. Our data and others show that 68-96% of these patients have incomplete or no
functional recovery of the diaphragm muscle. Despite varying causes of Phrenic Neuropathy, its
impact on respiratory function and individual quality of life is significant. At its worst, people with
Phrenic Neuropathy may require mechanical ventilation, but more typically they are severely
limited in their ability to engage in routine exertion required for activities of daily life. Currently,
clinical and surgical approaches do not sufficiently address the issue of slow axon regrowth.
Our project aims to rectify this by developing a Therapeutic Electrical Stimulation protocol
that can restore diaphragm muscle innervation and function faster and more completely than ever
before. Briefly, our approach is focused on three specific aims: 1) determining if repeated
Therapeutic Electrical Stimulation sessions are more effective than a single session, 2) assessing
if repeated sessions enhance brain-derived neurotrophic factor-TrkB signaling more than a single
session or control, and 3) establishing how essential brain-derived neurotrophic factor-TrkB
signaling is to the effects of Therapeutic Electrical Stimulation treatment. We aim to deliver a new
therapeutic electrical stimulation paradigm to accelerate diaphragm muscle innervation and
improve functional outcomes after Phrenic Neuropathy, providing new insights into the underlying
mechanism of how brain-derived neurotrophic factor-TrkB signaling can enhance muscle
reinnervation. The prior success of clinical translation from rat model to human clinical trials for
Therapeutic Electrical Stimulation to treat other nerve injuries implies a great opportunity to move
quickly towards clinical translation upon the successful completion of these aims.

Public health relevance
Project Narrative: This project aims to improve recovery from Phrenic Neuropathy, a neuromuscular condition that impairs the diaphragm muscle, causing breathing difficulties that lead to disability. Our team plans to use Therapeutic Electrical Stimulation, a method emerging as a clinical strategy to speed up nerve regrowth, delivered via a novel, wireless and bioresorbable implant. The main hypothesis is that this Therapeutic Electrical Stimulation protocol, via enhanced Brain-Derived Neurotrophic Factor (BDNF) signaling in motor neurons, will accelerate the nerve regrowth and reconnection to the diaphragm muscle and improve recovery from Phrenic Neuropathy.